New methods to prepare 1,4-oxazin-2-ones and applications in the construction of polysubstituted pyridines

Project Summary
This proposal describes the development of new methods for the preparation of 1,4-oxazinone
precursors and seeks to apply these intermediates to the construction of highly substituted
pyridine products through a merged cycloaddition/cycloreversion process. Oxazinones are
computationally and experimentally the most reactive precursor in cycloaddition/cycloreversion
sequences leading to pyridines, yet remain understudied and underutilized. The new synthesis
methods proposed for construction of oxazinones are direct, employ common starting
materials, and are supported by preliminary data. The planned applications of oxazinones for
the construction of polysubstituted pyridines will increase our understanding of the fundamental
reactivity of this heterocyclic ring system and seek to reveal some of the potential of
oxazinones relative to other [4+2]/retro[4+2] heterocycles used in pyridine synthesis. Pyridines
are one of the most prevalent structures imbedded within biologically active molecules. Thus,
new methods for the construction of pyridine motifs (especially those not easily accessed
through other methods) is merited and is acutely significant to the biomedical sciences.
In addition to foundational research, applications directed toward the synthesis of potentially
biologically relevant structures are included in the proposal. These include (1) a unified
synthesis strategy toward xylanigripone A and B, unique members of the ergot alkaloid family
that display pyridine and piperidine structures and (2) studies directed to the conversion of the
b-amino alcohol function in peptides bearing N-terminal serine and threonine residues into
reactive oxazinone intermediates. Computational efforts are proposed to compare peptide-
derived oxazinones prepared in this manner to other Diels-Alder reactive substrates, a prelude
to possible downstream bioconjugation applications.
William & Mary does not offer a doctoral degree in chemistry (BS/MS only); accordingly, my
research group is composed of undergraduate researchers (and one MS candidate). My
current research program creates a rigorous environment for learning and enforces teaching
and training in the one-on-one research experience. The proposed research would continue
within this climate and is designed at an appropriate level for students to make progress.
Support from the NIH would enable the research of 3-4 undergraduates and one Master's
candidate for each year of the award.

Public health relevance
Project Narrative 1,4-Oxazinones are reactive heterocyclic structures and can serve as precursors for the construction of highly substituted pyridine alkaloids. Pyridines are medicinally-privileged molecular scaffolds and polysubstituted pyridine variants are more challenging to access synthetically. New and efficient methods to prepare oxazinones and pyridines, as well as focused efforts to reveal new reactivity, will streamline biomedical research into these molecules and aid in the preparation of new biologically active entities as well as contribute broadly to fundamental chemical understanding of these molecules.